Minnesota Neuroimaging Postdoctoral Training Grant

Summary
The last decade ushered in amazing advances in neuroimaging due to transformative developments in
magnetic resonance and optical imaging techniques as well as in computational and modeling tools. A common
thread in these advances is their multi-disciplinary nature, requiring collaborations among medical
researchers, engineers, physicists, mathematicians, and data scientists, among many others. In order to
continue the pace of technical advances in neuroimaging and to exploit their unique capabilities for brain
research and medical applications, it is critical to train the next generation of neuroimaging specialists in a
setting 1) with an abundance of state-of-the-art tools, 2) with a programmatic interest in developing novel
neuroimaging technologies and biomedical applications, and 3) where trainees can carry out groundbreaking
research under multi-disciplinary mentorship. The University of Minnesota (UMN) has an excellent tradition
of training neuroimaging postdocs in its Medical School and its College of Science & Engineering. It is also the
home of major, world-renowned efforts in neuroimaging technology development and novel biomedical
applications of neuroimaging. The proposed Minnesota Neuroimaging Postdoctoral Training Grant aims to
give 14 postdoctoral fellows – at least 4 of whom will be from communities under-represented in STEM fields –
multi-disciplinary skills in neuroimaging technology development and advanced biomedical applications,
guidance in career development, and social and networking support through intense two-year neuroimaging
fellowships at UMN. Each fellow's primary research will be conducted on a multi-disciplinary project that
combines their background with another field with the express goal of developing new neuroimaging
technologies. Each fellow will be co-mentored by two faculty selected from the 40+ participating faculty in this
grant: one that will directly supervise the research project, and one that represents a core area related to the
research project. Fellows will take at least two courses to broaden their skillset and prepare for either an
academic or industry research career. They will participate in an Annual Retreat and twice-monthly seminars
that will cover research and career development topics such as responsible conduct of research, scientific rigor
and reproducibility, grant writing, and other key subjects. They will also participate in UMN's numerous
neuroscience conferences, symposia, and workshops, along with well-established UMN outreach programs to
high schoolers and undergraduates from communities under-represented in STEM fields. The program will be
managed by an Executive Board that represents the diversity of the participating faculty across the Medical
School and the College of Science & Engineering. Management plans include a rigorous, ongoing evaluation
process that incorporates an external Advisory Board and the University of Minnesota's internal research and
assessment services.

Public health relevance
Narrative Neuroimaging is a highly multidisciplinary field in which technology is rapidly developing, leading to a high demand for trained researchers in academia and industry. This program will provide postdoctoral fellows at the University of Minnesota research opportunities and training to prepare them for independent neuroimaging research careers that will help meet this demand.